The context-dependent role of Caveolin-1 as a driver of cellular adaptation in Ewing Sarcoma

Project Summary
My work aims to uncover non-genetic mechanisms that drive cancer cell plasticity. I focus specifically on Ewing
Sarcoma, a pediatric cancer driven by a single oncogenic fusion, making it prototypical for cancers whose
disease progression likely depends on non-genetic adaptations. During my postdoc thus far, I have developed
two complimentary models to study heterogeneity of cell states in Ewing Sarcoma: (1) a quantitative high-
resolution imaging assay that uses computer-vision based classification of single cell states within Ewing
Sarcoma xenografts in zebrafish, and (2) a bimodal distribution of cell signaling states characterized by
differential expression and organization of the scaffolding protein Caveolin-1. While the precise role of Caveolin-
1 in cancer remains controversial, recent works suggest that mechanical cues trigger changes in its localization
and activity, implicating Caveolin-1 as a potential integrator of environmental cues and cell signaling. However,
the mechanism of response and the ensuing signaling cascades remain to be understood, especially in the
context of cancer. Therefore, I will leverage the unique experimental frameworks I have established to test
whether Cav-1 acts as a plasticity factor promoting tumor cell adaptation in Ewing Sarcoma. This work will reveal
mechanisms of fast cellular adaptation to diverse microenvironmental cues which will provide unique insight into
the drivers of metastasis and drug resistance.
I am eager to build upon the foundations I have established during my postdoc thus far to discover previously
unapproachable mechanisms of cell adaptation. As the proposed work requires cross-disciplinary expertise, my
continued development in several areas will be instrumental to my progress. Dr. Danuser and the Danuser lab
will provide the ideal environment to develop advanced microscopy techniques and skills in computational
analysis of 3D data. Dr. Amatruda will provide guidance and support in the use of zebrafish disease models and
relevance to pediatric cancer. Dr. Lamaze and Dr. Cobb will provide scientific insight in caveolar biology, MAPK
cell signaling, and cancer biology. Combined with the stellar training environment and resources available at UT
Southwestern, this provides the ideal environment to carry out this work. The training I will receive will enable
me to lead an independent laboratory that studies cancer cell plasticity in a variety of experimental models, with
specific focus on imaging-based approaches and physiologically relevant environments.

Public health relevance
Project Narrative While the scaffolding protein Caveolin-1 has been implicated in disease progression in cancer, its precise role remains controversial. This proposal aims to leverage innovations in imaging, computational analysis, and zebrafish disease models to test the mechanosensory role of Caveolin-1 as a putative plasticity factor in Ewing Sarcoma, an aggressive pediatric bone and soft-tissue cancer. The anticipated results will reveal a mechanism of non-genetic cellular adaptation to diverse microenvironmental cues, providing unique insight into the drivers of metastasis and drug resistance.